Project 1 - Molecular mechanisms controlling TEC dynamics and lineage hierarchies in the perinatal thymus

Project Summary/Abstract
Thymic epithelial cells (TECs) provide growth and differentiation signals that are indispensable for the
development of T cells with a diverse, yet self-tolerant TCR repertoire. The number of TECs increases
exponentially in newborns as the thymus grows to support increased production of naïve T cells that are exported
to colonize peripheral lymphoid organs. The perinatal period is a time of dynamic changes in TEC subset
composition, differentiation, organization and function. Although the conversion of perinatal thymus growth to
juvenile thymus homeostasis is well established, the specific changes that occur in the composition of
transcriptionally distinct TEC subsets and identification of signaling pathways that initially promote and
subsequently limit expansion and remodeling of the TEC compartment are poorly understood. Furthermore, the
TEC progenitors in which such molecular re-programming events occur have not been defined. Our preliminary
data suggest that the Cyclin D1-retinoblastoma (RB)-E2F pathway is a key molecular switch that modulates TEC
proliferation during the perinatal to adult transition. We have shown that expansion of the perinatal TEC
compartment can be maintained into adulthood by deleting Rb family members or by expressing a keratin 5
driven Cyclin D1 (K5.D1) transgene to inactivate RB function. Our overall hypothesis is that perinatal and
juvenile TECs express distinct transcriptional profiles that coordinate TEC proliferation and differentiation, and
that the Cyclin D1-RB-E2F pathway regulates both processes. We propose a series of experiments that will test
this hypothesis and provide new insights into currently unresolved questions regarding the perinatal TEC
compartment. These questions include: 1) what changes occur in the composition of TEC subsets during the
perinatal to juvenile transition; 2) how do the transcriptional signatures of TEC subsets change across the
transition; 3) what molecular mechanisms and pathways regulate these changes; 4) what are the identities and
lineage hierarchies of TEC progenitors during the transition; and 5) do comparable cellular and molecular
changes occur in human TECs. The overall goal of RP1 is to resolve these knowledge gaps. In Aim 1, we will
use scRNA-seq to determine changes in the transcriptional profiles and advanced imaging to map localization
of transcriptionally distinct TEC subsets during the perinatal to juvenile transition. Parallel scRNA-seq and
imaging analyses will be performed on human TECs and thymus tissue. In Aim 2 we will perform in vitro and in
vivo assays to directly test the differentiation potential of candidate TEC progenitors identified in Aim 1. In Aim
3 we will determine whether molecular pathways that regulate TEC proliferation and differentiation are
coordinately linked by performing proteomic screens coupled with ChIP- seq analyses.